Healthcare System & Technology Design Core

ABSTRACT
The objective of the Healthcare System & Technology Design Core
(`Design Core') is to adapt and extend new methods for the design,
deployment and evaluation of technology-enabled services tailored for
older adults with multiple chronic conditions (MCC) and their caregivers.
We will translate innovative research in digital health, building to scale for
sustainable implementation in diverse primary care practices.
Significant enthusiasm exists for technologies to transform healthcare service
delivery. It has been proposed that technologies can improve quality and reduce
the cost of healthcare, increase a patient's capacity to successfully engage in
treatment decision-making and self-care behaviors, improve communication with
a primary care team, moving treatment outside of clinics into peoples' homes and deploy a variety of devices to
help embed services into the fabric of peoples' everyday lives. Unfortunately, for all the evidence demonstrating
that such technologies can work under controlled conditions, we have identified several failures of technology
development and evaluation that hinder meaningful impact on healthcare services for older adults with MCC.
The Design Core's goal is to spur research on the integration of technologies into healthcare services for older
adults with MCC and their caregivers. Our specific aims are to:
Aim 1 Provide expertise to investigators in the design, evaluation and implementation of technology-enabled
services for older adults with MCC and their caregivers.
Aim 2 Create a prototype technology-enabled service, designed for older adults with MCC and symptoms of
anxiety or depression, to communicate more effectively with their clinicians.
Aim 3 Develop and disseminate a methodology guide that summarizes best practices for applying user-
centered design (UCD) to optimize technology-enabled services for older adults with MCC.
The Design Core will become a national hub of expertise in the design and evaluation of technology-enabled
services for older adults with MCC (Aim 1). We will extend CBITs' expertise accumulated over 8 years and 70+
projects to support the design, development, and evaluation of technology-enabled services. We will devise an
MCC-specific technology design prototype through a `reference' project (Aim 2). We will then integrate our work
with other leaders nationally, producing an initial guide for supporting the development of technology enabled
services appropriate for primary care settings and among older adults with MCC (Aim 3).